AMBULATORY RECORDING OF DISTAL COLON, RECTAL AND ANAL CANAL MOTOR ACTIVITY

Better understand motor activity of the distal colon, rectum and anal canal in patients with chronic severe constipation and to gain experience with a newly developed ambulatory pressure probe and data acquisition device.